Role of N-alpha acetylation in mycobacterial secretion and virulence

DESCRIPTION (provided by applicant): 70-90% of all eukaryotic proteins are Nα-acetylated. There are seven established Nα-acetylated prokaryotic proteins. ESAT-6 (Early secreted antigen, 6kDa) is the only example of an Nα-acetylated bacterial virulence factor. ESAT-6 is secreted by ESX-1 (ESAT-6 system 1), a key virulence determinant in both Gram-positive and mycobacterial pathogens. The role of Nα-acetylation (Nα-Ac) of bacterial proteins in pathogenesis has not been investigated. The ESX-1 substrates require each other for export (coupled secretion). The mechanisms underlying coupled secretion are not known. The result is a fundamental gap in understanding how bacteria cause disease. The long-term goal is to understand the molecular mechanisms that underlie mycobacterial pathogenesis. The overall objective is to identify how Nα-Ac promotes mycobacterial pathogenesis. The central hypothesis is that Nα-Ac of ESAT-6 contributes to pathogenesis by directly mediating protein export by the ESX-1 system. The hypothesis is based on the applicant's preliminary data which show that altering Nα-Ac of ESAT-6 uncouples ESX-1 export and leads to attenuation. Therefore, the following specific aims have been proposed. 1) Establish how Nα-Ac promotes ESX-1 export 2) Determine how a novel gene in M. marinum pro- motes ESAT-6 acetylation 3) Identify the ESX-1-associated Nα-acetyltransferase in M. tuberculosis (M. tb). Under Aim 1, the link between Nα-Ac of ESAT-6 and coupled secretion will be investigated using molecular, biochemical and proteomic approaches. The scope of Nα-Ac in Mycobacterium will be addressed by identifying all of the Nα-acetylated proteins in M. marinum and M. tb using proteomics. Under Aim 2, the mechanism of Nα-Ac of ESAT-6 will be studied in vitro using biochemistry. A complementary genetic approach will identify residues in the putative ESAT-6 Nα-acetyltransferase required for Nα-Ac of ESAT-6 and for interaction with the ESX-1 apparatus. Finally, under the Aim 3, the tools generated in the M. marinum system will be used to identify the gene in human M. tb required for Nα-Ac of ESAT-6. The role of Nα-Ac in ESX-1 secretion and virulence in M. tb will be investigated. The proposed work will provide the first example of how Nα-Ac promotes bacterial pathogenesis and will result in an improved understanding of the molecular mechanisms of ESX secretion. This proposal is innovative because coupled secretion, one of the biggest outstanding questions in the ESX-1 field, is being approached by focusing on Nα-Ac, a likely overlooked protein modification in bacteria. The significance of the research proposed here is the identification and characterization of the first reported mycobacterial mutant strain with uncoupled ESX-1 substrate secretion, which will result in a vertical step in the ESX-1 field. Moreover, this proposal represents the primary step in understanding how Nα-Ac promotes bacterial protein secretion and pathogenesis, which will likely initiate a new field of study.

Public health relevance
PUBLIC HEALTH RELEVANCE: The proposed research is relevant to public health because understanding the basic mechanisms used by mycobacterial pathogens to cause disease is a critical step in developing new anti-Tuberculosis vaccines and diagnostics, which would help alleviate the current Tuberculosis epidemic. This research is relevant to the part of NIH's mission that concerns the pursuit of fundamental knowledge that is applicable to the development of scientific resources that promote disease prevention.